CASACONFERENCE, High Society: Substance Abuse and Public Policy

[unreadable] DESCRIPTION (provided by applicant): The CASACONFERENCE, High Society: Substance Abuse and Public Policy, will be held on February 14, 2008, from 8:30 a.m. - 4:00 p.m. at The Barbara Jordan Conference Center at The Henry J. Kaiser Family Foundation, 1330 "G" Street, NW, Washington, D.C. This conference will, in large part, build upon the findings of Joseph A. Califano's book, High Society: How Substance Abuse Ravages America and What to Do About It. Mr. Califano is the Chairman, President and Founder of The National Center on Addiction and Substance Abuse (CASA) at Columbia University. Mr. Califano is also a former U.S. Secretary of Health, Education, and Welfare. The CASACONFERENCE High Society: Substance Abuse and Public Policy will show healthcare practitioners, policymakers, and the American public that substance abuse and addiction causes and aggravates the nation's most wrenching social problems-violent and property crimes, soaring health care costs, family breakup, domestic violence and child abuse, the spread of AIDS, teenage pregnancy, poverty and low productivity. [unreadable] [unreadable] [unreadable]